Adaptive Protein Evolution of the Drosophila Germline Stem Cell Gene Bag of Marbles

PROJECT SUMMARY
Animals contain a small number of germline stem cells (GSCs) that are essential for making sperm or eggs.
The decision for a dividing stem cell to renew itself or to differentiate, and the regulation of early GSC divisions
are some of the most critical processes in development. Studies in the fruit fly, Drosophila melanogaster, have
identified many of the key genes involved in the cellular signaling for GSC maintenance and differentiation. We
have shown that the gene bag of marbles (bam), the key “switch” for GSC differentiation, is adaptively evolving
with a dramatic excess of amino acid substitutions in D. melanogaster, D. simulans, D. yakuba but not in six
other related species. During our current funding period we have generated new bam null mutations in
sequenced genomes of D. melanogaster, D. simulans, D. yakuba, D. teissieri, and D. ananassae to test for
conservation of function. These have allowed us to demonstrate that surprisingly unlike in D. melanogaster,
bam is not required for female GSC differentiation in D. teissieri nor is it required for male GSC differentiation
in D. teissieri and D. ananassae. We have shown that infection with different strains of the intracellular
endosymbiont Wolbachia pipientis vary in their degree of rescue of the fertility defects characteristic of the bam
hypomorph. This proposal focuses on identifying the functional and evolutionary consequences of observed
sequence diversification at bam and discriminating between the hypothesis that bam’s role in GSC function
has been selected for new functions, vs the hypothesis that interactions between bam and W. pipientis has
been the evolutionary force driving changes at bam. This includes generating and analyzing novel bam
hypomorphs in D. melanogaster and D. simulans, and testing interactions of these new hypomorphs with intra
and interspecific Wolbachia strains. We will carry out RNA-seq studies of the bam rescue by W. pipientis. We
are developing a computational model to generate experimentally testable predictions of sequence
diversification under several mechanisms of interaction between W. pipientis and GSC genes. Finally, we will
functionally evaluate evolutionary diversification of the bam protein sequence between D. melanogaster and D.
simulans, and the loss of the requirement for bam for female and male gametogenesis and fertility in D.
teissieri compared to its close relative D. yakuba. What we learn will contribute significantly to our
understanding of how GSCs are regulated during development in diverse species, how such critical
developmental functions can evolve, and how their mis-regulation due to mutation and interaction with
germline parasites can lead to infertility, germline cancers, and reproductive isolation.

Public health relevance
PROJECT NARRATIVE Germline stem cells (GSCs) are arguably the most fundamental cell type required for animal reproduction because these cells both maintain the germline throughout the animal’s life and produce the cells that go on to form either sperm or eggs. Remarkably, several key GSC regulatory genes are under strong natural selection for protein diversification between species of Drosophila. Our proposed study is aimed at identifying the functional consequences and correlated evolutionary pressures associated with the rapid protein evolution of bag of marbles, the key switch gene for GSC differentiation and its interaction with the intracellular bacterial symbiont, Wolbachia pipientis.